Mechanisms of Corneal Neuro-Immune Crosstalk

SUMMARY
Complex interactions between the nervous and immune systems, as main sensors of the body, play a
significant role in homeostasis of the cornea. Neurotrophic molecules are vital for maintenance of nerves in
peripheral tissues, however, despite our understanding on the impact and diversity of neurotropic molecules in
the cornea, their sources and the mechanism through which their production is regulated remains elusive. Our
preliminary results suggest that certain populations of leukocytes, in particular plasmacytoid dendritic cells
(pDCs), can serve as essential source of neurotrophic molecules. Thus, in this application, we propose
evaluating the contribution of each subpopulation of immune cells in providing corneal nerves with the
neurotrophic molecules and the signaling mechanism through which activation of immune cells through toll like
receptors (TLRs) may alter their neurotrophic properties. Further, we aim to assess if local adoptive transfer of
subpopulation of immune cells may enhance nerve regeneration following nerve damage in the cornea. We
also aim to determine if resident corneal immune cells regulate function of corneal nerves by depleting each
subpopulation of the resident corneal leukocyte and assessing electrical conduction of corneal nerves via
electrophysiological studies as well as measuring the response to painful stimuli in the pain centers in central
nervous system. Next, we propose to study how corneal nerves (both sensory and autonomic) may regulate
several steps in immune reaction, from up-regulation of adhesion molecules and increasing the permeability of
limbal vessels to recruitment of immune cells to the cornea and their intra-corneal locomotion. We suggest
studying how corneal nerves shape multiple functions of immune cells, including capacity of antigen uptake
and presentation to effector cells, profile of secretory cytokines, and angiogenic molecules. The application
proposes a paradigm shift on how corneal nerves may mediate immunity, and would potentially introduce new
immunomodulatory therapeutic strategies and targets for ocular as well as systemic inflammatory,
autoimmune, alloimmune and infectious diseases.

Public health relevance
NARRATIVE This proposal investigates the impact of various subpopulations of corneal leukocytes in nourishing corneal nerves with neurotrophic molecules and currently enigmatic mechanisms through which secretion of neurotrophic molecules is regulated. Further, we aim to assess therapeutic efficacy of local adoptive transfer of certain subpopulations of leukocytes in enhancing nerve regeneration in cornea following nerve damage. We also propose to study the mechanism through which corneal nerves mediate different aspects of immune response including recruitment, locomotion, and function.